Characterizing reactive balance after mild traumatic brain injury

PROJECT SUMMARY / ABSTRACT
Persistent balance problems are common sequelae after mild traumatic brain injury [mTBI]. Current
approaches to treat these balance problems traditionally focus on principles of sensory integration derived from
vestibular rehabilitation. However, recent evidence using destabilizing perturbations suggests that balance
deficits may originate from motor impairments, rather than sensory impairments. This reactive balance – the
ability to recover stability after an external perturbation – is an important domain of balance that is distinct from
static (i.e., standing) and dynamic (i.e., walking) balance tasks. Preliminary studies suggest this reactive
balance is impaired after mTBI, but the components underlying these impairments and the extent to which
these impairments manifest during daily life remain unclear. While reactive balance can be improved through
perturbation-based balance training in other populations, current clinical practice guidelines for the treatment
and management of mTBI provide no guidance on treating reactive balance. The objective of this study is to
understand the components underlying reactive balance deficits in people with mTBI and their impact on daily
life. The long-term goal is to guide targeted rehabilitation approaches that incorporate rapid motor responses
and reactive balance training to improve the function and quality of life for people with imbalance after mTBI.
Using a sliding platform and mechanized shoes, we will examine how mTBI affects reactive balance during
standing and locomotion, including walking and turning. Specifically, we will examine the two important
components of reactive balance: the ability to prepare (i.e., prime) a motor response in anticipation of an
upcoming perturbation and the ability to execute a motor response after a loss of balance. We will also develop
a method to assess reactive balance during daily life using wearable inertial sensors to assess reactive
balance during free-living daily mobility. Our aims will provide component-specific (Aim 1) and task-specific
(Aim 2) targets for future rehabilitation while exploring reactive balance during daily living (Aim 3). Combined,
these aims will provide the foundation for new, perturbation-based balance rehabilitation after mTBI, including
innovative methods to assess reactive balance during daily living, that can complement current standard-of-
care.

Public health relevance
PROJECT NARRATIVE Despite the high prevalence of persisting balance problems in people after mild traumatic brain injury [mTBI], our understanding and treatment of balance impairments remains incomplete. This study seeks to expand our knowledge of imbalance after mTBI by examining reactive balance – the ability to recover stability after a loss of balance. Ultimately, these results may provide the foundation for future rehabilitation approaches that incorporate reactive balance training to improve motor function after mTBI.